Examining the feasibility of a wearable device for fetal heart rate monitoring through interdisciplinary research

PROJECT SUMMARY
The overall maternal and infant health outcomes in rural areas of the United States depict a constant and growing
health need. Continued technological advances are needed to improve health care services and outcomes for
the most vulnerable populations. The long-term objective of this multidisciplinary team is to transition an
engineering prototype to a self-monitoring clinical prototype. The objective of this proposal is to develop the
functionality of a wireless, non-invasive skin-wearable fetal electrocardiogram (fECG) monitoring device based
on an accurate fECG extraction algorithm and cloud-based remote health monitoring to improve clinical care
among low-risk pregnant women in a rural community that is acceptable to prenatal healthcare services
consumers. To achieve the proposal objective, the study will focus on two specific aims: Aim 1 - development of
a wearable fECG monitoring device prototype via human subject-based testing in a rural based healthcare
setting; and Aim 2 - examining the acceptability of wireless wearable monitoring health devices among females
using community-based participatory research to understand the needs, perceptions, and preferences among
women who have previously been pregnant. The expected outcomes upon completion of this study are the
demonstrated functionality of the wearable fECG device and multiple sources of patient-centered data to support
the future use of the device. In the future, widespread use of the wearable device is likely to improve obstetrical
care for pregnant women through the ability to increase maternal mobility during labor and improved birth
outcomes for both women and infants. Future studies could enhance rural health care access by using the
wearable device remotely. These efforts align with the fifth NICHD theme to advance safe and effective devices
for pregnant women and the efforts include a multidisciplinary collaboration with researchers in fields from
engineering, nursing, and public health. Additionally, the research is community-based and includes a rural
underrepresented population.

Public health relevance
PROJECT NARRATIVE Technological advances through innovative wearable medical devices create an opportunity to address place- based health disparities in rural communities. Widespread use of a wearable fetal heart monitoring device is likely to improve obstetrical care for pregnant women through the ability to increase maternal mobility during labor and improve birth outcomes for both women and infants. The combination of sensor technologies, wearable electronics, and real-time remote health monitoring (with the potential of automated data analysis in near future) provide a unique opportunity to improve the quality of healthcare, decrease healthcare costs, and increase access to healthcare that could positively impact maternal and infant care, especially in rural and remote areas.